Understanding the mechanisms involved in HIV-1 CNS latency

In people with HIV (PWH), infected cells persist in several tissue compartments, including
brain and lymphoid organs, and can remain indefinitely during combination antiretroviral therapy
(cART). This persistence is due to the ability of the virus to establish a state of latency in cells,
where the proviral DNA remains transcriptionally silent for long periods. The central nervous
system (CNS) is considered one of the viral reservoirs due to the blood-brain barrier, resulting in
cellular compartmentalization and limited penetrability of some antiretroviral drugs. The primary
cells that serve as reservoirs in the CNS compartment are microglia, macrophages, and
astrocytes; however, very little is known about HIV-1 infection of these cells and the establishment
of HIV-1 reservoirs in the CNS. Studies evaluating latent resting CD4+ T cells in the periphery
have shown that epigenetic regulation, histone modification, transcriptional control and
methylation in the 5' HIV-1 long terminal repeat (LTR), which serves as the viral promoter,
facilitates viral latency. However, there remains limited understanding of how viral latency is
promoted and maintained in CNS microglia and macrophages. Accordingly, this proposal aims to
identify the key factors, pathways and their regulators, which determine the establishment and
reactivation of latent virus in the CNS. We hypothesize that HIV-1 latency establishment,
maintenance and reactivation in brain myeloid cell lineages are controlled by unique cellular
factors and their regulators specific to the CNS milieu that are distinct from latently infected CD4+
T cells in the periphery. Using our recently developed in vitro multicell lineage 3D-CNS organoids
with microglia from brains of HIV-1 positive donors, and infiltrating monocytes, a humanized
mouse model with infected microglia, and a precise Systems Biology approach, we will define the
on-off switches involved in myeloid cell reservoirs at the single cell level and HIV-1 latency in the
CNS. Successful completion of this study will identify new therapeutic targets (activators and
silencers) that are unique for myeloid cells in the CNS. A better understanding these factors can
improve treatment of PWH and can contribute to the development of a HIV-1 cure.

Public health relevance
Despite the successful control of the virus in people with HIV (PWH) with antiviral treatments, elimination or cure is impossible due to the presence of latently infected cells in various anatomical compartments including the brain and CNS. Given the deep breadth of knowledge on viral latency the peripheral reservoir cells (e.g. resting CD4+ T cells), several approaches for treatment exist, including “kick and kill” strategies, whereas, there is limited understanding of the myeloid cell viral reservoirs in the CNS. Using our recently developed novel multicellular human 3D-brain organoids with microglia from brain of HIV infected individuals, we will assess how HIV-1 establishes latency in these cells in CNS, that will help us to further develop therapeutic approaches to either activate and treat or silence the virus.